Systems Metabolomics Core

PROJECT SUMMARY
The regulation and mis-regulation of sphingolipid metabolism in acute myeloid leukemia (AML) occurs at
multiple bio-molecular levels—gene mutation, enzyme abundances and activities, as well as sphingolipid
precursors and products. The innovative aspect of the Program Project has systematically collected deep
biomolecular profiles of accrued patient samples and relevant AML cell lines. The new Systems Metabolomics
Core (Core C) will help the larger P01 project team to generate testable hypotheses by integrating the
systems-level datasets from individual research projects and the other research cores. The goal is to inform
critical Project-level decisions involving sphingolipid-targeted therapies. Core C will pursue the following
Specific Aims: 1) evaluate linear and nonlinear predictive models of outcome and response based on patient-
specific biomolecules and (cyto)genetics; 2) test data-driven predictive models of outcomes and response
based on patient-specific, gene–transcript–lipid–activity signatures; and 3) integrate gene, transcript, and
metabolite profiles of AML patients with a reconstructed sphingolipid module of the human metabolic network.
Core C leadership is comprised of experts in data-driven cancer modeling, metabolic network reconstruction,
and systems biology. Therefore, the Core is poised to adapt its approaches to the changing needs of the
individual research projects over the second term of the P01.

Public health relevance
PROJECT NARRATIVE The overall research team is collecting large, complex datasets from cancer patients, which must be analyzed comprehensively to inform critical decisions about the development of novel therapeutics. This shared resource core will act as a hub for individual research projects to combine their data types with those generated by others on the research team to make smarter choices about what targets to pursue in which patient subpopulations.